Program Leaders

Program leaders seek to support innovation while maintaining a steadfast focus on translational research. The Program currently thrives in a rich and diverse environment that encourages interaction and collaboration. The leadership seeks to provide the core infrastructure necessary to enable the work, and also to invest in key technologies and/or personnel to meet strategic goals.